Health-Related Quality of Life Among Adolescents and Young Adults Living with Chronic Hepatitis B: An Exploration of Family Context and Stigma

PROJECT SUMMARY
Children living with chronic hepatitis B (CHB) must actively manage their disease throughout their lifetime due
to the risk of progressive liver disease and hepatocellular carcinoma. Their transition to adult care complicates
care management and typically occurs during adolescence and young adulthood, when health-related quality of
life (HRQoL) can also diminish. The proposed mixed methods study seeks to provide insights into how family
context and stigma influence care management and HRQoL among adolescents and young adults (AYAs) with
CHB during their transition into adult care, with three specific aims: 1) To estimate the effects of family health risk
factors on HRQoL trajectories among adolescents with CHB and to determine whether they are modified by
family structure; 2) Explore care management experiences, including medical decision-making and adherence,
for AYAs with CHB transitioning into adult care; and 3) Identify how key moments, such as disclosure, secrecy,
and silence, from the family context form pivotal experiences that shape care management and HRQoL for AYAs
with CHB. First, the quantitative phase utilizes the Hepatitis B Research Network Pediatric Cohort Study dataset,
an investigation of HRQoL in youth with CHB in North America from 2010 to 2017, to examine how family context
influences HRQoL trajectories among adolescents with CHB. Next, the qualitative and participatory phases
involve primary data collection, leveraging the Johns Hopkins Viral Hepatitis Center. AYAs with CHB will be
recruited (n=15) from the Center for in-depth interviews to explore transitioning into adult care, medical
adherence, decision-making, and family communication and support. Second, all participants will be invited to
participate in Collaborative Filmmaking. This participatory method involves filmmaking and discussions to identify
how pivotal experiences within the family context have informed disease-related stigma and shaped care
management and HRQoL. Data integration will include visual displays whereby data are visualized alongside
each other. Participants will have the opportunity to incorporate their films into a composite film and share them
publicly. This study is an in-depth exploration of AYA chronic disease management and HRQoL that involves
public-facing work with the creation and dissemination of films. It is responsive to NICHD’s strategic plan theme
to improve child and adolescent health and transitions to adulthood, including healthcare transitions for those
with chronic health conditions. This research will provide foundational knowledge and actionable items for
families, health providers, and public health professionals to support AYAs with CHB transitioning into adult care.
The proposed research fulfills the dissertation and degree requirements for Ms. Block, PhD student at the Johns
Hopkins Bloomberg School of Public Health. Training will be mentored by experts in viral hepatitis, AYA health,
biostatistics, qualitative and participatory mixed methods, and translational science. With guidance from this
robust mentorship team (Sponsor: Dr. Jill Owczarzak), research and training will support Ms. Block’s growth into
an independent researcher dedicated to promoting the health and well-being of AYAs living with chronic disease.

Public health relevance
PROJECT NARRATIVE Children living with chronic hepatitis B (CHB) face an increased lifetime risk of progressive liver disease and hepatocellular carcinoma, requiring active disease management to optimize health outcomes. In alignment with NICHD’s strategic plan theme to improve child and adolescent health and transitions to adulthood, including healthcare transitions for those with chronic health conditions, this mixed methods study will explore how family context and stigma influence care management and health-related quality of life (HRQoL) among adolescents and young adults with CHB while they transition from pediatric to adult care. Findings will help create a strong foundation for long-term care management and support HRQoL as adolescents and young adults with chronic disease transition to adult care.